Understanding Utilization of Diabetes Self-Management Education and Support Using Social Network Analysis

PROJECT SUMMARY
Diabetes Self-Management Education and Support (DSMES) addresses the clinical, psychological, and
behavioral aspects of care needed to successfully self-manage diabetes. Despite the proven value of the
DSMES on patient outcomes, it remains underutilized. Only a small fraction of patients receive DSMES
within a year of being diagnosed with diabetes: 5% of those with Medicare and 6.8% of those with private
insurance. While the causes of low enrollment in DSMES are systemic and patient- and provider-based, the
role of the system-level factors, especially collaboration among providers, in DSMES utilization is not fully
understood. Since providers have a significant impact on whether patients attend DSMES, it is essential to
understand the practice patterns of providers regarding DSMES utilization. This K25 fills this gap in knowledge
by using 2 theoretical concepts—diffusion of innovations and social network analysis—to determine whether
patient-sharing relationships among the providers who care for patients with T2D is associated with DSMES
utilization. Aim 1 leverages health insurance claims for Medicare, Medicare Advantage and privately insured
patients to examine DSMES participation in Arkansas at the patient level. Aim 2 will construct a multilevel
network model comprising patients, providers, and a patient-sharing network of T2D providers. The network,
created using health insurance claims data, connects pairs of providers if they both deliver care to the same
patient. A multilevel statistical method, auto-logistics actor attribute models will examine whether the social
network structure of providers caring for T2D patients is associated with DSMES utilization. This project will
utilize membership, medical claims, and provider data for Medicare and Medicare Advantage enrollees (65
years old and above) and privately insured enrollees (aged 18 and above) from 2013–2020 from the Arkansas
All-Payer Claims Database.
The principles of innovation diffusion suggest that the rate of diffusion of the adoption depends on
influential members of the social system (i.e., opinion leaders) adopting an innovation and their decision being
communicated to other members, who then follow their lead. Aim 3 examines the feasibility of identifying
opinion leaders through the use of self-designating survey instruments, providing a foundation that can
potentially be utilized to enhance DSMES uptake among providers. These aims will serve as a system-science
methodological approach to understand DSMES utilization given patient and provider characteristics and
patient-sharing relationship among providers. Understanding the network structure of T2D providers will
facilitate the identification of network intervention strategies to promote DSMES referral behavior among
providers. This K25 will provide the investigator with foundational training in network science and diffusion of
innovations and is aligned with her long-term career goal of becoming a productive independent researcher in
designing network interventions to improve diabetes care.

Public health relevance
PROJECT NARRATIVE The utilization of Diabetes Self-Management Education and Support (DSMES) services is low, despite their proven benefits to patients. This study aims to understand factors associated with low utilization of DSMES and to identify potential DSMES provider opinion leaders by: (1) exploring the association of demographic, health status, provider availability, rural and urban residence status, and DSMES program density with DSMES participation at the patient-level by leveraging claims data from the Arkansas All-Payer Claims Database for Medicare, Medicare Advantage and privately insured patients; (2) constructing patient-sharing networks of providers who care for patients with type 2 diabetes (T2D) and applying social network analysis to determine whether patient-sharing relationships among providers is associated with DSMES participation; and (3) identifying the potential agents of change (i.e., opinion leaders) through self-designating surveys of providers. Delineating the social network of T2D providers yields the preliminary data needed to design effective interventions that can expand DSMES referral networks and enhance patient care.